30th Annual Midwest Microbial Pathogenesis Conference (MMPC)

PROJECT SUMMARY
The recent COVID-19 pandemic, alongside the rise and recurrence of infectious diseases, has underscored
the vital role of microbial science in addressing global public health challenges. The Midwest Microbial
Pathogenesis Conference (MMPC) stands as an influential annual scientific meeting dedicated to showcasing
exceptional research in microbial pathogenesis. MMPC focuses on nurturing the professional growth of junior
faculty, students, and postdoctoral scholars, with a specific focus on those historically underrepresented in
biological sciences, all while fostering an environment of diversity, equity, and inclusion for the exchange of
scientific ideas and collaborations. Since its establishment in 1994, MMPC has been hosted yearly at
academic institutions throughout the Midwest region of the United States. The steadily increasing attendance
of >400 participants encompasses undergraduate and graduate students, postdoctoral fellows, research staff,
and faculty, who engage in extensive interactions. Through career development forums, the "Meet the
Speakers" series, and informal gatherings during poster sessions, receptions, and meals, MMPC 2024 aims to
facilitate extensive networking among scientists and institutions across the Midwest and beyond. The
conference's regional accessibility, affordability, and substantial financial support for travel and registration
make it possible to attract a diverse array of participants. This meeting has been consistently supported by the
NIAID over the past 14 years, and here, we are requesting continued support for MMPC 2024-2028. The 30th
annual MMPC will be hosted by Indiana University in Bloomington, Indiana from September 6th-8th, 2024. In
alignment with MMPC's rich tradition, >85% of the invited speakers (excluding the keynote and opening
session speakers) will be trainees or junior faculty. Of the 15 invited faculty speakers, >50% are women and
include diversity in terms of personal backgrounds, geographic origins, and research topics within the field of
microbial pathogenesis. Additional oral presentations will be selected from abstracts submitted by students and
postdoctoral fellows. As part of our commitment to promoting diversity and excellence, we aim to use funding
from this grant application waive registration and lodging fees for 20 scholars who are women and/or from
underrepresented groups. Further, we will waive the registration fee for an additional meritorious 13 trainees.
MMPC 2024 will feature a keynote address by Dr. Kim Orth from the University of Texas Southwestern Medical
Center, an esteemed HHMI Investigator, a Burroughs Wellcome Fund Investigator, and a member of the
National Academy of Sciences. Dr. Orth will present her groundbreaking research on how pathogenic bacteria
invade host cells and cause disease. Support of this R13 grant application from the NIAID will facilitate the
assembly of a diverse group of scientists from various microbiology subdisciplines, encouraging collaborative
networks and advancing the careers of the next generation of scientists.

Public health relevance
PROJECT NARRATIVE The Midwest Microbial Pathogenesis Conference (MMPC) is a distinguished regional scientific meeting that promotes research at the intersection of disease and pathogenesis mechanisms. The focus of MMPC aligns with the mission of the National Institutes of Health to research the causes of diseases to improve human health and to develop fundamental and innovative scientific resources for the biomedical community. MMPC brings together hundreds of researchers with an emphasis on trainees and junior investigators to develop connections to nurture career development and research progress, all while fostering an environment of diversity, equity, and inclusion for the exchange of scientific ideas and collaborations.